Alternaria and ribonucleases in Th2-type immunity

DESCRIPTION (provided by applicant): The long-term goal of this project is to better understand the immunologic mechanisms of asthma and allergic diseases. These diseases are generally thought to result from dysregulated immune responses to environmental proteins and organisms, which are mediated by Th2 cells. However, several fundamental questions still remain. How do patients develop such maladaptive T cell responses? Why don't all patients who have detectable serum IgE antibodies (e.g. patients with allergic rhinoconjunctivitis) develop asthma? By using the Alternaria fungus, which has been implicated in human asthma, we have been studying how allergen-specific CD4+ T cells develop and which allergen molecules are critically involved. We now hypothesize that the so-called Th2-type immune response to airborne allergens is mediated by two distinct CD4+ T cell subsets, namely Th2 cells and follicular T (Tfh) cells, which are critically involved in eosinophilic inflammation and gE antibody production, respectively. We also hypothesize that exogenous and endogenous ribonucleases (RNases) are involved in development of pathologic Th2 cells. In Aim 1, we will use mouse models and determine the roles of Th2 cells and Tfh cells in Th2-type airway immune responses to Alternaria and other airborne allergens. We will leverage cytokine reporter mice and gene-deficient mice and investigate the compartmentalized development of Th2 cells and Tfh cells. In Aim 2, we will investigate the roles of Tfh cells in human airway disease. We will characterize blood CXCR5+CD4+ T cells, a human counterpart of Tfh cells, in a cohort of patients with short ragweed hay fever and examine the dynamic changes in these cells during the hay fever season. In Aim 3, we will determine the roles of Alternaria-derived RNases and endogenous RNases, such as eosinophil-derived neurotoxin, in development and exacerbation of Th2 type immune responses. We will integrate data obtained from in vitro experiments and in vivo mouse models. Recombinant Alternaria RNases and the fungi deficient in these RNases will be examined. The technical expertise required for these three Aims is readily available in the laboratories of Dr. Kita and his collaborator, Dr. Lawrence, a fungal functional genomics expert. The proposed studies are likely to provide a better understanding of the fundamental mechanisms underlying the development of Th2-type immunity to airborne allergens and will provide an explanation for the dissociation between robust airway inflammation and IgE antibody production in certain patients with allergic airway disorders. The study will also likely identify potential key environmental and endogenous molecules that participate in the development of pathologic T cell responses in asthma. Ultimately, these studies will significantly enhance our understanding of the key cellular pathway(s) and molecule(s) involved in allergen- induced airway inflammation, allowing for identification of critical targets for development of novel therapeutic strategies to treat or to prevent asthma and related airway disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Patients with asthma have persistent respiratory health problems. This project will investigate how common environmental fungi and other allergens cause, prolong and intensify this disease.